Adding Residential Address History Data to Project Talent: Unveiling the Long-Term Effects of Neighborhood Characteristics on Cognitive Risk and Resiliency

Alzheimer’s disease and related dementias (ADRD) are progressive diseases whose etiologies are characterized
by a combination of age, genetics, and environmental factors. However, the impact of environmental factors on
ADRD risk and resilience remains unclear due to a lack of contextual data from across the life course. Research
investigating the impact of neighborhood characteristics on health outcomes is largely cross-sectional, and
most longitudinal cohort studies lack lifetime residential address history data. Augmenting longitudinal cohort
studies with neighborhood-level contextual data can accelerate our understanding of how the places we live
influence cognitive health trajectories. The purpose of this project is to develop a residential address history to
include all addresses across adulthood for each participant in the Project Talent (PT) cohort—a nationally
representative sample of older adults in the United States. Project Talent includes a rich source of adolescent
and early adulthood data. We will geocode each address to develop a geospatial data set consisting of ZIP codes
and census geographic designations. This data set will facilitate linking PT data to contextual data sets to
support research on the cumulative impact of social and environmental factors on cognitive health trajectories.
This project is responsive to the National Institute on Aging Strategic Plan Goals B, F, and G, and to NOT-
AG-21-045—specifically, augmenting existing longitudinal cohort studies to address questions related to
ADRD. Aim 1: Develop a residential history data set of Project Talent participants. We will identify
PT participants in the LexisNexis database and collect all recorded physical street addresses from 1960 to the
present to develop a comprehensive history of places participants lived across adulthood. Based on previous
work conducted over the past decade, we anticipate that we will successfully link approximately 80% (n =
301,613) of the sample to a unique record in LexisNexis. We will also collect the time at each residence (date
first seen and date last seen) to develop a residential history data set.
Aim 2: Geocode lifetime residential addresses of Project Talent participants. We will geocode each
address in the PT residential address history data set to generate geographic coordinates. We will partner with
GeoLytics, a commercial geocoding vendor, to process street addresses into spatial coordinates and capture
census geographic designations (e.g., block group and tract codes) for each available decade.
Aim 3: Develop and disseminate geospatial data sets. We will develop a geospatial data set that
includes ZIP codes and census geographic designations across each available decade (1960–2020), and time
(year first seen and year last seen) at each location. This data set will facilitate linking PT data to contextual
data sets to collect policy, social, and environmental exposures over time, laying the foundation for research on
the cumulative impacts of exogenous factors on health trajectories, including ADRD risk and resiliency. The
data will be made available at no cost to researchers through AIR.

Public health relevance
The purpose of this project is to collect residential histories of Project Talent participants, geocode street addresses, and develop a geospatial data set that includes geographic coordinates, ZIP codes, Census codes, and time (first and last year seen) at location. The project will make the data available at no cost to researchers, who may use the data to link Project Talent survey data to contextual data sets from other sources like the Census, Dartmouth Health Atlas, and Environmental Protection Agency. Project Talent is a study partner with the NIA’s Data LINKAGE program, providing researchers with access to health outcome data including data on ADRD diagnoses and comorbidities.